Mechanisms of Trauma-Induced Coagulopathy

Program Summary/Abstract
The fundamental objective of our Trauma Research Center Training Program is to inspire the next
generation of surgical trainees to pursue a career that includes basic science and translational
investigation. At a time when surgical scientists are becoming rare, this training grant is critical to maintain the
participation of clinically active surgeons in basic research. While our Center’s primary focus is Trauma-Induced
Coagulopathy and Inflammation, we believe the diversity of opportunities within our Program, and general
applicability of the coagulation/inflammation process to other disciplines, ensures relevance to any surgical
trainee. Our secondary objective is to recruit capable surgeons to the field of academic trauma surgery in which
lack of research has become a national crisis. Trauma remains the leading cause of death in the US for
individuals younger than 46 years of age with bleeding the primary cause of these preventable deaths.
Hence the need for basic and translational investigation in this area is essential and remains our inspiration.
The design of our Program is a two-year full-time commitment to basic investigation conducted
primarily in well-established surgical research laboratories within the University of Colorado Anschutz Medical
Campus, supplemented by patient data generated from prospective clinical studies at our regional Level I Ernest
E Moore Shock Trauma Center at Denver Health. Experimental work will focus on the mechanisms disrupting
coagulation-inflammatory homeostasis, and includes investigation with proteomics, metabolomics, and
genomics.
The major funding for this basic research will be the 1RM1GM13968 “Resuscitation Strategies for
Achieving Thrombo-inflammation Homeostasis” funded by NIGMS, UM1HL120877 TACTIC funded by NHLBI,
and DOD-W81XWH – 12-2-0028 “Acute Coagulopathy of Trauma” funded by the Department of Defense.
Clinical studies will be funded dominantly by the DOD W81XWH–12-2-0028 W81XWH-16-D-0024 “Linking
Investigation in Trauma and Emergency Service Clinical Research Network” (LITES) as well as a number of
institution and industry supported trials. The surgical research fellows will commence participation in the
Program after the second or third year of general surgery residency (PGY 2 or 3) for two consecutive years.
We encourage pursuit of advanced degrees, e.g. MS, MPH, and PhD, with training in the School of Graduate
Medical Education.
As in the past, we are requesting funding for four positions annually, sequenced so that first and second
year fellows are assigned to our core laboratories.

Public health relevance
Project Narrative The fundamental objective of our Trauma Research Center Training Program is to inspire the next generation of surgical trainees to pursue a career that includes basic science and translational investigations. Our secondary objective is to recruit capable surgeons as surgical investigators to the field of academic trauma surgery, in which lack of research has become a national crisis. As trauma continues to be the leading cause of death for individuals younger than 45 years of age, and the most common cause of preventable death is uncontrolled bleeding, training the next generation of clinician investigators in this field is our fundamental goal.